Administrative Core

Core A provides experienced administrative and financial support for the overall Program Project. Administrative support includes organization of the monthly scientific meetings, planning of review committee member' s visits (internal and external), creation of all reports including the regular progress reports and noncompetitive renewal application forms, record keeping for minutes of meetings, and general correspondence and office support. Financial oversight includes the management of budgets, accounting, purchase orders, personnel actions, standing orders, Fed Ex, and travel.. A plan for the replacement of the PI if necessary is outlined. The organizational structures are included and a designee for administration is defined in the PI's absence.

Public health relevance
N/A